1998 THROUGH 2003 ANNUAL NRSA TRAINEES CONFERENCE

The purpose of this application is to request support over the next five years for the annual NRSA Trainees Research Conference for trainees supported by the Agency for Health Care Policy and Research (AJCPR), the Bureau of Health Professions of the health Research Services Administration (HRSA) through their national Research Service Awards (NRSA) programs, and for primary care and health services research trainees supported by other federal agencies. The meeting is designed to advance three specific goals: 1. To foster collaborative working relationships across institutions and research disciplines. 2. To offer trainees the opportunity to receive outside critique andreview of their research projects to improve health services research design and methods. 3. To offer trainees the opportunity to meet experts and colleagues in health services research who can help advance their academic and career goals. The NRSA Trainees Research Conference takes place annually, in conjunction with the annual meeting of the Association for Health Services Research. The Trainees meeting is an academic even dedicated to furthering the scholarship of trainees at different NRSA program sites and to broaden and encompass other programs. The meeting is designed to provide opportunities for trainees to learn about feedback on their individual projects.